600 MHz NMR Spectrometer and CPMAS CryoProbe

Project Summary:
We propose the acquisition of the first CPMAS cryoprobe for solid-state NMR to be housed in the
United States, along with a dedicated 600 MHz NMR spectrometer to support biomolecular research
at UC Riverside and the surrounding Southern California region. The increased sensitivity of this
instrument will enable transformative research projects supported by NIH funding that include:
heterochromatin formation and gene silencing, structural transformations of neurodegenerative
disease related proteins (amyloids), membrane protein effectors of pathogen interactions with the
host, mechanistic enzymology and chemical structure/dynamics of pyridoxal-5'-phosphate-dependent
enzymes, inhibition of β-lactamases, and the mechanics of biopolymers. These problems all share a
common need for molecular characterization at the limits of experimental sensitivity. Although well-
equipped for solid-state NMR with conventional and dynamic nuclear polarization (DNP) enabled
detection, there are currently no facilities within Southern California or North America with the
sensitivity of the requested instrumentation for samples that must be maintained at or near room
temperature. As such, this equipment will fill a noticeable void in the types of NMR characterization
that can be performed both regionally and nationally. The proposed cryoprobe and spectrometer will
become part of the University of California at Riverside’s Analytical Chemistry Instrumentation
Facility, which serves the campus, local community, and external users from across the country.

Public health relevance
Project Narrative: The relationship between structure and biological activity drives the development of therapeutic agents. Here we propose to add a significant molecular imaging capability through the addition of a high sensitivity solid-state nuclear magnetic resonance cryoprobe and dedicated spectrometer. The goal is to determine the molecular level details that govern structure-function relationships and that inform our chemical intuition for designing novel, next-generation treatments. PHS 398/2590 (Rev. 05/01) Page pn - 1 Continuation Format Page